Dissecting the differential role of TREM2 and TYROBP in microglial homeostasis, activation, and disease

PROJECT SUMMARY/ABSTRACT
The Alzheimer’s Association describes Alzheimer’s disease (AD) as “the most common type of
dementia”, a term that generally describes the loss of memory and some forms of cognitive skills that interfere
with everyday activities. AD is one of the top three causes of death in aged individuals in the United States. It
was first described by Alois Alzheimer in 1906 as an accumulation of extracellular amyloid plaques and
intracellular neurofibrillary tau tangles; yet, more than a century later, there is still no effective treatment or cure
to the disease. Although an abundance of research has focused on understanding AD, there are still many
unknowns to the mechanisms of disease pathogenesis.
Microglia, the primary immune cell in the brain, have multiple activation phenotypes that are involved in
broad and complex functions in the brain, including in neurotoxicity and release of inflammatory cytokines, in
repair and regeneration, in immune regulation, in neuroprotection and release of anti-inflammatory cytokines, in
cell survival/proliferation/migration, and in phagocytosis. TREM2 and TYROBP are known to form a complex in
microglia that can lead to complex intracellular signaling networks, and these proteins have recently emerged
as important regulators of the transition between resting (homeostatic) microglia and its activation states. Recent
findings from our group and others have shown a TYROBP-dependent and TREM2-independent molecular
signature that exhibits involvement in the early transition step from homeostatic microglia to disease-associated
microglia (DAM). Interestingly, the sequential step of DAM activation is TREM2-dependent. However, the
underlying mechanisms of how TREM2 or TYROBP regulate these downstream cellular phenotypes are largely
unknown.
In this proposal, we aim to systematically test whether, and to what extent, AD-relevant stimuli, such as
amyloid beta (A) oligomers or physiological Apolipoprotein E 3 or 4 isoforms are able to activate microglia, in
the absence of TYROBP or TREM2 or in the presence of the AD-associated Trem2 R47H knockin mutation.
Here, we will utilize a thorough approach to investigate not only signal transduction and various cellular activation
pathways, but also we will use state-of-the-art mass spectrometry-based phosphoproteomics to unbiasedly
examine global changes in phosphopeptides, in order to specifically elucidate differences in microglial
homeostasis and activation states in our models. The overall goal of the study is to understand the differential
roles of TREM2 and TYROBP in the mechanisms underlying microglial activation in the context of disease-like
stimuli, and to ultimately identify potential therapeutic targets that specifically focus on microglia activation
phenotypes, and that could contribute to the delay or treatment of AD pathology.

Public health relevance
PROJECT NARRATIVE During normal aging and neurodegenerative diseases, such as Alzheimer’s disease (AD), a subpopulation of microglia, the primary immune cell in the brain, has been shown to change their phenotype to ‘disease- associated microglia’ (DAM), characterized by an upregulation of genes important for microglial activation and inflammation. Key mechanisms of the transition of microglia to the DAM state, as well as the role of key microglial regulators, such as TREM2 and TYROBP, are complex and not thoroughly understood. Therefore, this study proposes to dissect the involvement of the TREM2/TYROBP axis in microglial homeostasis and activation, in the context of exposure to AD-relevant stimuli, in order to discover new potential therapeutic targets and to provide new insights on the role of microglia in AD pathogenesis.